2023 Viruses and Cells Gordon Research Conference and Gordon Research Seminar

PROJECT SUMMARY
The objective of the 2023 Viruses and Cells Gordon Research Conference (GRC) is to highlight the most
significant and impactful virology research and stimulate new collaborations by recruiting a diverse spectrum of
leading-edge virologists from around the globe. We also aim to foster career development opportunities for
graduate students and postdoctoral fellows before the start of the Viruses & Cells GRC for students and
postdoctoral fellows by hosting an associated 2-day Gordon Research Seminar (GRS). The GRS will provide a
unique platform for PhD students, postdoctoral fellows and young researchers to present their cutting-edge
work to an international audience of their peers through both talks selected from abstracts and an evening
poster session. Held every other year since 1995 (with the exception of 2021 due to the pandemic), the
Viruses and Cells GRC is one of the most successful of the prestigious international scientific conferences
organized by the GRC and encompasses a remarkable breadth of seminal virology in an exceptionally
interactive, 200 person setting. These include the most novel aspects of viral replication, viral pathogenesis,
virus-host interactions, and antiviral therapies. Significant attention is being given to the assembly of a program
that is scientifically outstanding and represents a diverse spectrum of virologists. This includes geographic
location, career stage, gender balanced, and inclusive of individuals from underrepresented backgrounds. The
conference will bring together established investigators at the forefront of the field, junior investigators
launching independent research careers, scientists from industry, postdoctoral fellows, and graduate students,
to discuss new ideas and foster collaborations to advance the most innovative and broadly impactful areas of
viral research.

Public health relevance
NARRATIVE Viruses are critically important pathogens and have a tremendous impact on public health worldwide; they are major causes of respiratory illness, food insecurity, infant and childhood morbidity and mortality, and cancer. Emerging viruses continue to pose threats to the public health systems of many nations. The Viruses and Cells Gordon Research Conference is one of the most important meetings in virology and serves to disseminate the newest breakthroughs in the biology, pathogenesis, and emerging therapeutic angles for these diverse viruses in an interactive forum, thereby stimulating new ideas, new collaborations, and new innovation to combat ongoing and future viral threats.